TECHNICAL SUPPORT FOR SEER-MEDICARE DATA USERS

This contract is in support of the Surveillance, Epidemiology, and End Results (SEER) Program managed by the Surveillance Research Program of the National Cancer Institute.